Design Improvements and Evaluation of a Knee Stress-Relief Powered Exoskeleton for Veterans with Knee Osteoarthritis

Knee osteoarthritis (OA) is a growing problem due to increased longevity and obesity with estimates of 14 million
people living with this impairment. Knee OA results in decreased activity and lifestyle changes, further
exacerbating an individual’s health. Exoskeleton technology (Keeogo™, B-temia, Inc.) may be a viable alternative
to standard knee OA treatment by providing powered support to reduce pain during mobility. Preliminary
studies with the Keeogo™ in six persons with knee OA showed efficacy for pain reduction during different
mobility tasks. However, a tuning guide to promote better usability by clinicians and Veterans with knee OA,
knowledge about the biomechanics of how the device provides active assistance, and an in-laboratory evaluation
of performance outcomes compared with standard knee braces are lacking. Absence of published prescription,
tuning and general guidelines for use in Veterans with knee OA were also identified as limitations.
This proposal has four aims: Aim 1) to develop a knee OA-specific tuning guide for KeeogoTM that would
maximize user mobility activities with reduced pain across different levels of severity of knee OA; Aim 2) to
examine the biomechanical responses of Veterans with knee OA to the active assistance provided by the Keeogo™
as compared with the passive assistance provided by standard knee braces; Aim 3) to evaluate in-laboratory
mobility outcomes, pain perception, and user satisfaction with the KeeogoTM as compare with standard knee
braces; and Aim 4) to develop recommendations for prescribing and tuning the use of knee OA exoskeleton
devices. Aims 1 and 4 are development projects and no hypotheses are generated. The two hypotheses (H) to be
tested for Aim 2 are: H2.1) in stance phase, walking with KeeogoTM will show less knee adduction moment
(KAM), knee flexion moment (KFM), and muscle co-contraction than walking with standard knee braces. These
variables have been shown to be related to internal joint loading as well as disease progression and pain; H2.2)
in swing phase, walking with KeeogoTM will show greater knee range of motion (ROM), stride length, and foot
clearance than walking with standard knee braces. These variables have been shown to be related to antalgic gait
as a result of knee pain. The two hypotheses to be tested for Aim 3 are: H3.1) to show improved performance
outcomes on mobility tests, including a 6-minute walk test, timed up and go test, 13-step stair test, pick up penny
from floor test, and the Short Physical Performance Battery (SPPB) when using the KeeogoTM as compared with
their prescribed knee braces and H3.2) to show reduced pain with the KeeogoTM by the numeric pain rating scale
(NPRS) as compared with their prescribed knee braces for the mobility tests.
The study will be conducted at two VA medical centers. The knee OA-specific tuning protocol will be developed
(Aim 1) and used in the in-laboratory evaluations (Aim 3) in 20 and 26 Veterans with knee OA, respectively, at
the James J. Peters VA Medical Center, Bronx, NY. The biomechanical studies (Aim 2) will be conducted in 24
Veterans with knee OA at the VA Pittsburgh Health System-Human Engineering Research Laboratories,
Pittsburgh, PA. The investigators from both sites will work together to write the prescription and tuning
guidelines (Aim 4) for public use.
Expected outcomes: The tuning guide will facilitate quicker fitting and parameter adjustment, the biomechanics
studies are expected to identify underlying mechanisms of action during device use, the in-laboratory study is
expected to demonstrate improved walking velocities, stair ascent/descent times, improved sit-to-stand, stand-
to-sit, and object retrieval from the floor with reduced patient-reported pain; and the knee OA-specific
prescription and tuning guidelines will be deliverable for public use.

Public health relevance
Knee osteoarthritis (OA) is a growing problem among active duty military and Veterans. Knee OA clinics are experiencing steady increases in patients throughout the VA. Few interventions are available which include weight management, knee braces, pain medications and/or surgery. However, these efforts to mitigate knee OA are often ineffective. Development of exoskeletons may offer a potential solution for Veterans with knee OA to reduce pain while walking and performing mobility-related activities of daily living (ADLs) with the potential to reduce pain medication intake and delay/reduce the need for knee replacement surgery. If successful, this project will provide Veterans with knee OA a useful alternative to standard braces and other non-surgical treatments. Reduction in knee pain with improved walking velocity and performance of ADLs would help to improve daily physical activity levels for Veterans with knee OA. New protocols for testing exoskeleton technologies for ambulation and ADLs and knee OA-specific guidelines for clinicians and users will be delivered.